Coordination for ARDS, Pneumonia, and Sepsis supporting Training, Organization and Network Efficiency (CAPSTONE)

The ARDS, Pneumonia, and Sepsis (APS) Coordinating Center will support a highly functional
and integrated clinical and translational research infrastructure that will enhance the quality and
scientific rigor of the research conducted by the APS Phenotyping Consortium. We are a team
composed of leading content and methods experts at Vanderbilt, Johns Hopkins, and University
of California San Francisco. We will provide Coordination for ARDS, Pneumonia, and Sepsis
supporting Training, Organization and Network Efficiency: ‘CAPSTONE’. We will support the
clinical centers (CCs) in enrolling and sustaining a diverse cohort; enable the efficient and
standardized capture of multi-modal cohort data with repeated measurements; model the data to
understand mechanistic underpinnings of APS, including the interplay of underlying and static risk
factors; and segment the population into similar prognostic and predictive phenotypes. This will
enable scientific progress towards a deeper mechanistic understanding of critical illness
syndromes and recovery. Functionally, we will 1) Implement the study design, data capture, and
statistical analysis unit. Coordinate protocol development; establish a REDCap-based data
collection, management, and security framework; conduct and support analyses; generate
reports; make curated data widely available for research through a facilitated storefront; 2)
Implement the clinical research management unit. Maintain cohort integrity and adherence to the
protocol and manual of operations, perform routine monitoring of data quality and site
performance; training of study staff; image and biospecimen management. Support site
communications; facilitate recruitment and retention; and 3) Implement the stakeholder
engagement and development unit. Establish bidirectional, longitudinal engagement from diverse
communities; help CCs build and sustain trust; ensure strengths of each CC are nurtured and
shared; facilitate dissemination of findings; support skills and career development among
research teams. Our efforts will expand foundational work on APS phenotyping, identify gaps,
and help create methods for redefining critical illness syndromes with the ultimate goal of
improving and personalizing management strategies that will curtail the devastating morbidity and
mortality caused by APS.

Public health relevance
The proposed ARDS, Pneumonia, and Sepsis (APS) Phenotyping Consortium Coordinating Center, CAPSTONE, will be a highly functional and integrated coordination and support infrastructure that will raise the quality and scientific rigor of the research conducted by the APS Phenotyping Consortium. The team, composed of leading content experts at Vanderbilt, Johns Hopkins, and University of California San Francisco, will simultaneously harmonize the needs of varied stakeholders; guide design, analysis, and data collection; and keep ahead of technical, societal, and medical evolutions. CAPSTONE will expand foundational work on APS phenotyping, identify gaps, and help create statistical and other methods for redefining critical illness syndromes with the ultimate goal of improving and personalizing management strategies that will curtail the devastating morbidity and mortality caused by APS.